Netrin-1 Signaling in Ischemia Reperfusion Injury of the Kidney

DESCRIPTION (provided by applicant): Acute kidney injury (AKI) is a common disorder with an exceedingly high morbidity and mortality. Inflammation plays an important role in the pathogenesis of AKI. Molecules are exists to control inflammatory process however, the mechanisms through these molecules suppress inflammation and how inflammatory processes overcome the suppression to induce renal injury are remains poorly understood. The objective of this application is to determine the mechanisms by which activation of signaling pathways by netrin-1 lead to protection of kidney against ischemic reperfusion injury. Netrins are a family of neuronal guidance cues highly expressed in vascular endothelial cells and their receptors were expressed both in circulating leukocytes and endothelial cells. Our central hypothesis is that netrin-1 inhibits leukocyte migration and inflammation acting via the UNC5B receptor expressed on the leukocytes and vascular endothelial cells resulting in reduced inflammation and increased perfusion of the kidney. This hypothesis is based on our extensive preliminary data which clearly indicate that netrin-1 expression down regulated in endothelial cells after ischemia reperfusion of kidney and administration of recombinant netrin-1 protected ischemia reperfusion injury of the kidney and reduced inflammation. We plan to test our hypothesis and achieve the objective of this application by pursuing the following three specific aims: #1) Determine the receptor(s) which mediate netrin-1 protective effect against ischemia reperfusion of the kidney. #2) Determine the signaling mechanism through which netrin-1 mediates effect on renal parenchymal cells and leukocytes. #3) Determine the mechanism of netrin-1 mediated protection against ischemic renal injury. The proposed work is innovative because the role of netrin-1 and their receptors in AKI is unknown. Our expectation is that the results will provide novel insights into the mechanisms whereby netrin-1 signaling regulate inflammation and subsequent protection of structural and functional damage. It will also discover new information defining the regulation of epithelial and endothelial functions by netrin-1 signaling in response to ischemic renal injury.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed studies will elucidate the key role of netrin-1 receptors in the netrin-1 mediated protection of kidney against ischemia reperfusion injury. They will also define the central role of kidney netrin-1 receptor signaling in regulating migration of inflammatory cells infiltrate into kidney. These results will be relevant because they are expected to lead to clinical trials to test the efficacy of recombinant netrin-1 and other signaling pathway inhibitors for the prevention or treatment of acute renal injury. NARRATIVE The proposed studies will elucidate the key role of netrin-1 receptors in the netrin-1 mediated protection of kidney against ischemia reperfusion injury. They will also define the central role of kidney netrin-1 receptor signaling in regulating migration of inflammatory cells infiltrate into kidney. These results will be relevant because they are expected to lead to clinical trials to test the efficacy of recombinant netrin-1 and other signaling pathway inhibitors for the prevention or treatment of acute renal injury. __SpecificAimsTextDelimiter__ A. Specific Aims: Acute renal failure (ARF) is an important clinical problem which is often caused by ischemia of the kidney. The incidence of acute renal failure in patients who undergo cardiac bypass surgery is up to 30% (Rosner and Okusa, 2006). The mortality of ARF has remained high, at approximately 50%, over the last 50 years despite advances in supportive care (Vijayan and Miller, 1998). The outcome is worse in the intensive care setting, where ARF frequently coincides with the multiorgan dysfunction syndrome (Liano et al., 1998). The cost for each year of survival following ARF is over $50,000/patient (Radhakrishnan and Kiryluk, 2006). There is no effective therapy currently available for ischemic ARF. Thus, new therapeutic approaches are desperately needed. Several in vivo animals studies strongly support an important role for inflammation and vascular damage in ischemic kidney injury (Rabb et al., 2000; Rabb et al., 1995; Rabb et al., 1995; Haq et al., 1998; Kelly et al., 1994); however, the mechanisms and molecules which control inflammation and the mechanism by which inflammation produces kidney injury remains poorly understood. Netrins are prototypical axonal attractants and play an important role in axon guidance during development (Barallobre et al., 2005). Recent studies indicate that netrin-1 is a potent stimulator of angiogenesis and an inhibitor of leukocyte chemoattraction in vivo (Ly et al., 2005). Although the kidney has one of the highest levels of netrin-1 expression, the role of netrin-1 in ischemic kidney injury is unknown. Such knowledge is crucial to the development of new therapeutic approaches of inflammatory kidney disease Figure 1. Overview of proposed studies. such as ischemia reperfusion injury. Based on our published Netrin-1 observation (Wang et al., 2008), we propose that down regulation of the chemorepulsive cue netrin-1 in vascular Aim #1 endothelial cells after ischemia reperfusion, predisposes the UNC5B (-) (+) kidney to leukocyte infiltration and injury. Our long-term goal is to reduce the mortality and Leukocytes Endothelial and morbidity associated with acute renal failure by targeted epithelial cells intervention based on cellular and molecular mechanisms. In Adenylate ERK, AKT and MNK Aim #2 preliminary studies, we have determined that administration cyclase/cAMP of netrin-1 reduces renal ischemic injury (Wang et al., 2008). Inhibition of Anti-apoptosis, The objective of this application is to understand how netrin- activation, cell proliferation 1 lessens ischemic renal injury. The central hypothesis is Aim #3 Canhdemoigtaraxtiison MInitgergartiitoyna,nVdapsceurfluasrion that netrin-1 inhibits leukocyte migration and inflammation acting via the UNC5B receptor expressed on the leukocytes and vascular endothelial cells resulting in reduced Reduced renal injury inflammation and increased perfusion of the kidney. We formulated this hypothesis based on substantial preliminary data described later. The rationale behind these studies is that once the mechanism of netrin-1 mediated protection is understood, the pathways can be manipulated using innovative approaches for the prevention of ischemic acute renal failure. As is illustrated in the above figure 1, we plan to test our hypothesis and achieve the objectives of this application by pursuing the following three specific aims: Specific Aim #1: Determine the receptor(s) which mediate netrin-1 protective effect against ischemia reperfusion of the kidney. Our studies demonstrate that administration of recombinant netrin- 1 to mice before renal ischemia reperfusion, protects against kidney injury. Netrin is known to bind to two different families of receptors (DCC and UNC5A-D) and mediate different physiological effects in different cells and tissues. The receptor subtypes which mediate the netrin-1 protective effect is not known. Our preliminary studies show that UNC5B, UNC5C and neogenin are highly expressed in kidney whereas only UNC5A and UNC5B are expressed in leukocytes. In vitro studies have determined that netrin-1 proliferative effect is mediated through UNC5B. The working hypothesis for this aim is that netrin-1 mediates its protective effect through UNC5B. We will test this hypothesis by using neutralizing antibodies to netrin-1 receptors, siRNA and immunohistochemistry to determine the receptor subtype which mediates netrin-1 effect in kidney pathophysiology. Specific Aim #2: Determine the signaling mechanism through which netrin-1 mediates its effect on renal parenchymal cells and leukocytes. The signaling pathways through which netrin-1 mediate its action are poorly understood. Moreover, nothing is known in kidney tissues and leukocytes. Our preliminary studies show that the addition of netrin-1 to kidney epithelial and endothelial culture activates variety of pathways known to be involved in cell proliferation and migration which include ERK, Akt and Mnk-1. The working hypothesis for this aim is that netrin-1 binding to UNC5B activate ERK and Akt pathways in renal parenchymal cells but activate adenylatecyclase/cAMP pathways in leukocytes to increase cell survival, proliferation and chemorepulsion respectively, thereby reducing renal injury. We will use pathway-specific inhibitors, neutralizing antibodies against specific receptors, siRNA and knockout animals to study the proposed mechanisms. Specific Aim #3: Determine the mechanism of netrin-1 mediated protection against ischemic renal injury. Our preliminary studies demonstrated that netrin-1 promotes renal epithelial cell proliferation and migration in vitro through UNC5B. In addition, UNC5B expression was found on T and B-lymphocytes, macrophages and neutrophils. Recent studies suggest that netrin-1 is a potent inhibitor of trans- endothelial cell leukocyte migration. Ischemia is characterized by inflammation associated with the production of inflammatory cytokines and leukocyte infiltration. The working hypothesis of this aim is that netrin-1 reduces ischemic injury through inhibition of leukocyte migration, down regulation of chemokines and adhesion molecules, and an increase in blood flow resulting in reduction of leukocyte infiltration and renal injury. We will use transgenic animals, which over express netrin-1 in the kidney, tissue-specific knockout animals, flow cytometry, and neutralizing antibodies to study some of the proposed mechanism. The proposed work is innovative because the role of netrin-1 in ischemic injury to the kidney, or to any other organ, has never been studied. From the results of the proposed studies, we expect to have novel insights into the mechanisms whereby netrin-1 transduces the signal to suppress leukocyte activation and migration in response to ischemic insult of the kidney and subsequent protection of the kidney from structural and functional damage. The proposed studies will also define the regulation of renal tubular epithelial and endothelial proliferation and migration by netrin-1 in response to ischemic renal injury. This information is critical to a broader understanding of the mechanisms of renal recovery and regeneration. These results will be significant because they are expected to lead to clinical trials to test the efficacy of recombinant netrin-1 for the prevention or treatment of acute renal injury. In addition, these studies will identify potential new signaling intermediate, which could be used as target for clinical interventions.